Partial Antagonists of mGluR5 for Treatment of Cocaine Addiction

DESCRIPTION (provided by applicant): The metabotropic glutamate receptor (mGluR) mGluR5 subtype plays a critical role in regulating the rewarding effects of drugs of abuse and recent studies suggest that selective mGluR5 antagonists may provide an exciting new approach for treatment of addictive disorders. We have identified multiple new mGluR5 antagonists, including multiple unique scaffolds as well as compounds based on existing scaffolds that have novel activities. Most notably, we discovered a novel class of compounds that act as highly selective partial antagonists of mGluR5. Unlike partial agonists that have been identified for other receptors, these compounds do not activate the receptor to any level. However, they partially block activation of the receptor by glutamate without fully blocking receptor activation. We now have multiple partial antagonists that block mGluR5 with a range of activities from 10% to 90% inhibition when the allosteric binding site on the receptor is fully occupied. This exciting breakthrough would not be possible with traditional competitive orthosteric site antagonists but is achieved by targeting the allosteric antagonist site. By employing high throughput medicinal chemistry techniques we will optimize these screening leads into compounds suitable for proof of concept studies. These novel compounds will provide an unprecedented opportunity for our labs to determine whether partial blockade of mGluR5 will have effects in animal models that predict efficacy in treatment of cocaine abuse or whether complete blockade of the receptor is required. Also, these agents will allow us to directly evaluate the adverse effects of mGluR5 antagonists that possess different levels of mGluR5 blockade. In addition, our new understanding of partial antagonist activity will allow us to optimize compounds belonging to existing partial antagonist scaffolds as well as novel chemical classes to identify optimal properties to be used as research tools and drug leads. This research has direct relevance to the mission of NIDA and has the potential to impact human health directly. Our goal for this project is to develop a partial mGluR5 antagonist with an acceptable profile for preclinical and ultimately clinical development that may become a new drug to treat addictive disorders.